Two photon fluorescence microscopy for dermatologic surgery and biopsy

Medicare reimburses over 5 million biopsies resulting in 1.5 million surgical procedures annually for
nonmelanoma skin cancer (NMSC). Despite its burden on the health care system, treatment remains time-
consuming and unevenly available due to inefficient histologic methods used for diagnosis and to guide therapy.
As an alternative, two photon fluorescence microscopy (TPFM) combined with rapid molecular labeling
can evaluate histology dramatically faster than conventional methods. We have developed high speed TPFM
imaging for dermatologic surgery, protocols for rapid molecular labeling of human tissue, and conducted
preliminary studies showing that TPFM can evaluate skin cancer with similar accuracy to conventional
histology. Our approach addresses the limitations of current methods, which begin with diagnosis, where the
delay for histology means that patients must return for a second clinic visit if biopsies are positive. Inefficiencies
are compounded during therapy, where in standard excision the delay for processing means that histology is
evaluated postoperatively, and a second surgery may be required to complete therapy. Alternatively, in Mohs
surgery, intraoperative frozen sections may be used, resulting in a substantial increase in procedure time and
reduced clinic capacity. As a result, costs are increased and access to care is subject to regional variations, with
patients in rural areas more likely to receive substandard care that puts them at risk for disfigurement or tumor
recurrence. The goal of this research program is to advance two photon imaging technology for surgical
applications, and then conduct clinical trials testing the use of TPFM in both diagnostic biopsy
procedures and in surgical treatment of NMSC. The aims for this proposal are: Aim 1 will develop improved
TPFM that incorporates recent advances in detector and laser technology to reduce cost, shrink size, and
enhance contrast, providing an efficient new tool for diagnosing and treating NMSC. Concurrently, studies will
examine the accuracy of TPFM for a less common type of skin cancer. Aim 2 will study patients undergoing
dermatologic biopsy, testing the hypothesis that patients can be immediately diagnosed using TPFM, enabling
same visit treatment for common skin cancers. Finally, Aim 3 proposes interventional surgical trials. Aim 3, Task
1 will integrate TPFM into Mohs surgery, testing the hypothesis that faster histological imaging can accelerate
treatment. Aim 3, Task 2 will introduce TPFM for margin evaluation into standard (non-Mohs) excision of skin
cancer, testing the hypothesis that TPFM can be used in a scenario for which no intraoperative imaging is
currently practical. Collectively, these aims will test more efficient methods of diagnosing and excising skin
cancer, accelerating treatment, reducing costs and morbidity while expanding access to care. Successful
completion of this project would demonstrate powerful new tools for general surgical pathology and validate
them for use in dermatologic surgery.

Public health relevance
Project Narrative This proposal investigates the use of two photon fluorescence microscopy as tool to evaluate biopsies and surgical margins of nonmelanoma skin cancer. New technology will be developed that accelerates imaging speeds and reduces the cost of treatment. Clinical studies are proposed that will investigate both real-time diagnosis of biopsies and the evaluation of surgical margins using two photon fluorescence microscopy in a dermatology clinic.